Mouse Metabolic Function & Phenotyping Core

Rodent models of diabetes and its complications have and will continue to provide fundamental insights into
the molecular basis of human metabolic disease. The investigators of the Columbia DRC employ many
murine models to study diabetes and its complications. Characterizing the phenotype of these animals in an
efficient, effective and timely fashion is critical for the productive study of diabetes at Columbia. The Mouse
Metabolic Phenotype & Function Core (MMFP) has been in great demand during the current funding cycle
and has evolved significantly since the last submission to meet the changing needs of DRC investigators.
The MMFP has proven broadly successful in achieving its mission of assisting individual investigators in
characterizing metabolic phenotypes of mice, fulfilling more than 18,000 service requests for 80 scientists
in the laboratories of 22 DRC members, supported by 58 grants. The Core has been instrumental in
obtaining 14 new grants, and in 72 publications (44 as primary Core). The MMFP currently provides
services that facilitate the efficient characterization of mouse models of diabetes and its complications: NMR
Body Composition Analysis, Whole Body Metabolic Assessment (chamber calorimetry with motion
detection), Metabolic Clamps, Gastric Infusion/Feeding and Thermogenic Phenotyping. Importantly, Core
personnel also provides guidance to investigators regarding selection of techniques and experimental
design. The MMFP services complement those provided by other DRC Cores, so that investigators who take
advantage of DRC resources can fully characterize the histologic, immunologic and metabolic function and
phenotypes of mice. The Core has been built through the strong support of the Naomi Berrie Diabetes
Center and Columbia University. To continue effectively serving the needs of the Columbia diabetes
research community, the MMFP has evolved by adding and expanding services. In response to investigator
surveys and as proposed in our last competing renewal, we developed three phenotyping services during the
current funding period: Metabolic Clamps, Gastric Infusion Program and Thermogenic Phenotyping
(controlled ambient temperature; cell and tissue calorimetry). These services are now well established.
Projections indicate that demand for these Core services will remain high.

Public health relevance
The ability to perform advanced metabolic phenotyping of rodent models of diabetes, obesity, and insulin resistance, is essential to the operation of a modern Diabetes Research Center. The Mouse Metabolic Phenotype and Function Core has fulfilled this mission by offering high-quality characterization of mouse metabolism. With the implementation of new services this Core is poised to continue to provide critical support to DRC Activities.